Dissecting the role of ventral pallidal projections to nucleus accumbens in reward processing

N/A- Not required for supplement request

Public health relevance
N/A- Not required for supplement request